AUTOLOGOUS PLATELETS IN IMMUNE THROMBOCYTOPENIC PURPURA

The primary aim of this study to show that oral tolerance can be used to treat ITP. Orally introduced platelets can increase the platelet count of ITP patients.